DEVELOP NEW COMMERCIALLY VIABLE DEVICES, TOOLS, TECHNOLOGIES OR INTEGRATED SYSTEMS FOR DRUG DETECTION AND DEACTIVATION TO DETER OPIOID THEFT IN HOSPITALS.

DEVELOP NEW COMMERCIALLY VIABLE DEVICES, TOOLS, TECHNOLOGIES OR INTEGRATED SYSTEMS FOR DRUG DETECTION AND DEACTIVATION TO DETER OPIOID THEFT IN HOSPITALS.